Data Core

PROJECT SUMMARY
The Data Core (DC) aims to become a shared resource and research hub that leverages campus-wide
resources and expertise across the University of New Mexico (UNM) and UNM Health Science Center, and
provides investigators with one-stop service, support, and collaboration regarding data acquisition, processing,
harmonization, access, synthesis, integration, and dissemination (APHASID). The DC will develop a cutting-
edge, web-based platform for the APHASID of multi-sectoral data, including, but not limited to, disaster data
(e.g. wildfires, flood, hurricanes), air pollution (remote sensing and environment monitoring), physical and
social stress on communities (e.g. built environment), healthcare systems and resources, health services and
outcomes. The DC will work closely with the Admin Core and Community Engagement Core (CEC) to support
all research projects, pilots, and spin-off projects within the CHANGES center. Specifically, the DC will adapt
and deploy state-of-the-art methodologies and models (e.g. multiple-interrupted time series models and
prediction of ambient black carbon due to wildfires) to support the proposed research projects. The DC will
engage the CEC and cater to our community data needs, including providing training and dissemination to
support citizen data science and community resilience. By becoming a data hub for climate-related health
research and community action, the DC will be an essential part of UNM’s infrastructure for climate change
and health in New Mexico and beyond.